Cardiovascular Scientist Training Program

PROJECT SUMMARY/ABSTRACT
The training program described in this renewal application represents a new paradigm for training academic
cardiologists as cardiovascular scientists, based on the UCLA STAR (Specialty Training and Advanced
Research) Program combining clinical subspecialty training with research training leading to a Ph.D. or
Masters degree. This program has been in existence here at UCLA for 24 years and has trained over 44
cardiovascular scientists and researchers. M.D. trainees will complete 2 years of subspecialty cardiology
training and 3-4 years of research training that fulfills the requirements for a Ph.D. degree in one of the basic
sciences or Health Service Research/Outcomes/Policy, or a Masters of Clinical Research, including formal
course work and research leading to successful thesis defense. M.D./Ph.D. trainees undergo 2 years of post-
doctoral research training, including elective course work. Six positions are requested, to provide support for
the research training component only. The training faculty consists of 35 senior preceptors and 11 supporting
faculty. Only senior preceptors may serve as primary research mentors, and they come from 8 groups: the
UCLA Cardiovascular Research Laboratory, the UCLA Atherosclerosis Research Unit, the UCLA Cellular &
Molecular Cardiology Unit, the Broad Stem Cell Research Center, the UCLA ACCESS Program (a multi-
departmental program administering Ph.D. training in life sciences), the School of Engineering, the
Biomathematics Department and, for health services research, the UCLA School of Public Health and RAND
Graduate School. Supporting faculty do not act as primary mentors, but play a key role in enhancing the
overall research environment and fostering translational research from the basic to the clinical arena. The
research programs of the faculty are supported by over 50 million dollars in direct costs annually from
extramural sources. By integrating cardiology subspecialty training with the formal recruitment of Ph.D.
training (or equivalent post-doctoral training for those already having a Ph.D.), the UCLA Cardiology STAR
Program provides graduates with the rigorous research background essential to translate the unparalleled
advances in molecular health sciences into modern molecular medicine.

Public health relevance
PROJECT NARRATIVE The UCLA Cardiovascular Scientist Program is specifically designed to combine comprehensive research training leading to a Ph.D. degree or equivalent with subspecialty training in clinical cardiology for M.D.'s. The goal of this program is to provide cardiologists with highly competitive research training, allowing them to translate advances in basic research to the clinic, or to address health service issues critical to society.